Mechanisms of Interferon-Lambda Programming at the Innate-Adaptive Immune Interface for Protection Against Virus Infection

Project Summary. The innate-adaptive immune interface represents the site of action where components of
both innate and adaptive immunity cross-engage each other to program the effector actions of the adaptive
immune response. The actions of the innate-adaptive immune interface are considered essential for
establishing protective immunity and immune memory against virus infection. Type III interferon (IFN-λ) is a
cytokine that functions at the innate-adaptive immune interface and is critical for mediating innate immune
protection at mucosal barriers. IFN-λ provides therapeutic benefit against Influenza A virus (IAV) infection,
however how it operates within the innate-adaptive interface is not defined. We have utilized a murine model of
IAV infection to study the contribution of IFN-λ in regulation of immunity at the innate-adaptive interface during
respiratory virus infection. Our studies show Ifnlr1-/- mice have blunted effector CD8+ T cell responses
compared to WT mice and exhibit reduced survival upon heterosubtypic IAV re-challenge. Analysis of dendritic
cells (DCs) reveals that IFN-λ signaling directs CD103+ DC migration and function to develop optimal anti-viral
CD8+ T cell responses. Further, preliminary bioinformatic analysis suggests IFN-λ is essential for control of an
Il10 immunoregulatory network in DCs during IAV infection. Our observations reveal that IFN-λ bridges innate
and adaptive immunity to direct DCs to program effective T cell immunity against IAV. We hypothesize IFN-λ
signaling in DC regulates an IL-10 program critical for development of effective T cell memory for lasting
immunity against IAV. Thus, the studies in this proposal aim to: 1) determine the contribution of IFN-λ to
generation of memory CD4+ and CD8+ T cell responses and 2) elucidate IFN-λ regulation of IL-10 in
programming DC functions. Results from these studies will define the role of IFN-λ at the innate-adaptive
immune interface in programming effective immunity against IAV infection and inform IFN-λ-based vaccine and
immune therapy strategies to prevent and limit infection.
!

Public health relevance
Project Narrative. IFN-λ contributes to immunity against influenza A virus (IAV) infection at the interface of innate and adaptive immunity, but how IFN-λ regulates the protective capacity of adaptive immune responses is not known. Our work has identified a critical role for IFN-λ in regulating DC responses to activate CD8+ T cells during IAV infection. The work proposed here will define the contribution of IFN-λ to the development of memory CD4+ and CD8+ T cell responses and define the mechanisms by which IFN-λ programs DCs, revealing the full potential of IFN-λ as a therapeutic against IAV. !